Synaptopodin and its role in Shigella flexneri intercellular spread

Project Summary/Abstract
Shigella are bacterial pathogens that are a major source of moderate-to-severe diarrhea, and globally, a leading
cause of long-term disability and disease in children. Illness necessitates Shigella invade epithelial cells lining
the colon and then spread between the cells of the epithelial monolayer. This type of spread enables bacteria to
avoid immune detection while acquiring nutrients and increasing the size of their replicative niche, thus
intercellular spread is essential for severe disease. To spread, Shigella repurposes the actin cytoskeleton to
acquire actin-based motility within cells. Shigella that move to the plasma membrane deform it into structures
known as protrusions. These protrusions are essential for spread, because they enable bacteria to push into
adjacent, uninfected cells. While these macroscopic steps are known, the molecular mechanisms that drive them
are much less understood. Here, I propose to study the molecular mechanisms for how synaptopodin (Synpo)
promotes Shigella flexneri intercellular spread. Our data demonstrate that Synpo is required for disease caused
by S. flexneri, as it is essential for the bacteria to spread between cells. We show that Synpo enables the
formation of longer actin fibers within the actin tail and enhances the efficiency of protrusion formation. It is
unclear how Synpo promotes these processes, my preliminary data show S. flexneri infection alters the
phosphorylation state of Synpo within defined or predicted protein interaction domains. I hypothesize that the
phosphorylation state of Synpo is altered during infection such that Synpo forms a complex with distinct proteins
during infection, enabling the recruitment and function of these proteins at sites of bacterial protrusion formation
and sites where bacteria polymerize actin. To test aspects of this hypothesis, I propose the following aims: Aim
1. To define whether phosphorylation of Synpo is necessary for S. flexneri intercellular spread. Aim 2. To define
whether Synpo promotes localization of host proteins to S. flexneri during infection. The completion of these
aims is likely to define new mechanisms about how Synpo functions in cells and about how bacteria spread
intercellularly. These approaches will further define the role of post-translational modifications of Synpo, identify
proteins that interact with Synpo, and determine how Synpo is localized to particular positions within the cell.
Further, many pathogens that cause diarrhea require mechanisms similar to Shigella, suggesting that my studies
are likely to yield general insights into how pathogens cause diarrheal disease.

Public health relevance
Project Narrative Shigella flexneri is a major source of diarrheal illness with severity of illness being directly related to the ability of S. flexneri to spread intercellularly between monolayers of intestinal epithelial cells within the colon. Whereas the major steps of intercellular spread are known, the bacterial-host interactions that occur, which allow S. flexneri intracellular passage from one cell to an adjacent cell are not well understood. This proposal aims to define the molecular mechanisms for how Synaptopodin promotes S. flexneri intercellular spread thereby increasing severity of diarrheal illness.